Structure, dynamics, and mechanism of genome packaging motors in dsDNA viruses

Project Summary/Abstract
The mechanism of DNA packaging for double-stranded DNA viruses will be studied in the Bacillus
subtilis bacteriophage φ29, the most efficient in vitro viral packaging system known. Using an
integrated genetic, biochemical, single-molecule and structural approach, we will characterize
protein conformational change and movement in the transiently assembled packaging motor during
DNA encapsidation. The mechanism of packaging in φ29 will serve as a model for animal virus
packaging in the analogous herpesvirus and adenovirus systems, and aid in the search for new
antiviral therapies. Due to similarities between the φ29 ATPase and other ring translocases, insights
gained from the study of φ29 packaging will also provide insight into the basic principles of
macromolecular motor function in higher organisms. As part of our long-term and multicomponent
efforts to interrogate the mechanism of DNA packaging, here we will: 1 – Characterize the
structure, dynamics, and energy landscape of DNA packaging motors. In Aim 1.1, we will use
standard cryoEM SPA and nested highly focused reconstructions to test structural predictions of the
helical to planar model. In Aim 1.2: we will utilize advanced image processing approaches to
characterize the dynamics and energy landscape of packaging motors, and 2 – Complete single-
molecule studies of ring motor mechanism. In Aim 2.1 we will use single molecule optical laser
tweezers to dissect how key residues participate in critical functions during DNA translocation.
Further, we will utilize combined single molecule imaging and force measurements to characterize
DNA rotation during DNA packaging (Aim 2.2) and to correlate changes in motor conformation with
DNA translocation (Aim 2.3).

Public health relevance
Project Narrative The assembly and movement of macromolecules in biological systems drive all aspects of health and disease at the cellular level. Study of the structure, assembly and function of the bacterial virus φ29 DNA packaging motor serves as a model for understanding these fundamental biological principles and can inform us about similar processes in higher organisms. The DNA packaging process of φ29 will also serve as a model for understanding similar events in the medically relevant herpesviruses and adenoviruses, thus providing targets for the development of new antiviral therapies.